FDA Veterinary Laboratory Investigation and Response Network Cooperative Agreement Program

Project Summary/Abstract
The objective of this Food and Drug Administration (FDA) Veterinary Laboratory Response Network (Vet-
LIRN) Cooperative Agreement Program is to enable the analyses of animal diagnostic samples, animal
foods, and animal drugs when laboratory investigations or surge testing are needed for analyses related
to research and testing of microbiological or chemical contamination, either through intentional or
unintentional means.
This program will increase the ability to conduct investigations via laboratory analysis by supporting new
and rapid analytical techniques and providing for well-equipped and staff laboratory facilities. The
outcomes will result in increased Vet-LIRN laboratory research and capacity to investigate potential
animal foodborne illness outbreaks by fostering training, the use of new technologies, and improving
the effectiveness of collaborative partnerships.
Funding offered by this program can provide laboratories with the infrastructure to enhance their
testing capabilities for both microbiological and chemical methodologies. These cooperative agreements
are also intended to expand participation in networks to enhance Federal, State, local, and tribal food
safety and security efforts.

Public health relevance
Project Narrative This FDA Vet-LIRN Cooperative Agreement Program will strengthen collaborative efforts among Federal, State and local resources to promote animal health and increase food safety and security efforts. This program will bolster laboratory testing by advancing methodologies used to detect animal food for adulterants and contaminants, protecting both food and companion animals and public health.